Elastase and Elastin Peptide Activity in Age-Related Macular Degeneration

The long-term goal is to understand the fundamental basis of complement signaling in the eye, and how
misregulation in this process leads to pathology, to ultimately aid in the development of therapeutic ap-
proaches for devastating blinding diseases. BrM, a pentalaminar extracellular matrix compartment, contains
a middle elastic layer (contains elastin, EL). Thickness and integrity of this EL is thinner and less abundant
in the macula than in the periphery; a discrepancy that is more severe in early AMD and active choroidal
neovascularization (CNV). AMD patients have elevated serum EL-peptide and anti-EL antibody levels; and
EL-peptides can increase choroidal endothelial cell migration, overall suggesting that abnormalities in EL
homeostasis play a role in AMD. We have characterized a mouse model of smoke-induced ocular pathology
(SIOP) in C57BL/6J mice. These mice exhibit increased serum levels of anti-EL antibodies (Abs, IgG2a),
and show a complete loss of integrity of the elastic layer. Conversely, mice immunized with oxidized EL
(neoepitope) develop more severe vision loss and pathology in BrM when compared to those immunized
with control EL (self-protein). We are guided by our overall hypothesis that age- and/or stress-dependent
increase in elastase activity leading to elastin degradation and coordinated production of (anti) α-elastin Abs
are early events in AMD. We further hypothesize that α-elastin Abs binding to FcγRs trigger antibody-
dependent cell-mediated cytotoxicity, exacerbating AMD pathology, a mechanism that is amplified by com-
plement-dependent cytotoxicity. Also, we suggest that alpha-1 antitrypsin (A1AT), an endogenous elastase
inhibitor, can be utilized to retain BrM integrity as a potential early AMD therapy. Three specific aims are
designed to determine the involvement of antibodies against elastin in BrM pathology in mouse models, and
second to test the prediction that A1-AT reduces pathobiology in mouse and man, using A1-AT for thera-
peutic purposes in mouse models and analyzing the MarketScan Database for A1-AT use and AMD onset.
The novelty of the idea is that elastase activity results in structural pathological changes (elastin loss, in-
flammation), and it is highly innovative that an existing elastase inhibitor will be tested for its ability to pre-
serve BrM integrity, as a treatment paradigm to slow down the progression of disease early in the process.

Public health relevance
Studies have shown that oxidative stress, elastin-layer breakdown, antibody production and complement activation are fundamental components of age-related macular degeneration (AMD). Our preliminary studies in cell and animal models of disease, suggest that elastase activity might be involved in complement activation, potentially playing a role in the pathobiology of AMD. We have designed experiments to explore the roles of elastase and elastin-fragments as well as the elastase inhibitor alpha-1 anti trypsin in RPE function and health.